Development and Evaluation of EHR-enabled Population Health Outreach Strategies to Improve Diabetes Screening in a Safety-net Health System: a Pragmatic Randomized Controlled Trial

PROJECT SUMMARY/ABSTRACT
Type 2 diabetes (T2D) screening remains suboptimal in spite of well-recognized, national screening guidelines.
In the US, 7.3 million adults with T2D and 74.5 with prediabetes (PDM) remain undiagnosed. In spite of
opportunistic screening in clinical practice, nearly one-third of primary care patients have undiagnosed
dysglycemia (PDM + T2D). To close screening gaps, new strategies are needed. We adapt evidence-based
approaches from cancer screening to conceptualize T2D screening as a multi-step process (risk assessment,
screening invitation, test ordering, and test completion) requiring coordination across patient, provider, and
health system interfaces. We previously developed the Parkland Dysglycemia Detection Program (PDDP) –
an EHR-based, multicomponent population health T2D screening intervention that automates risk assessment,
bulk orders screening tests, and facilitates bulk patient outreach via screening invitations. The PDDP closes
multiple gaps in the screening process and supplements opportunistic screening in clinical practice. In our
PDDP pilot study, a single, generic ‘overdue for screening’ invitation had a 41% response rate vs. 13% in usual
care alone. Of those completing screening, 37% had PDM and 5% had T2D, representing cases ‘missed’ by
opportunistic screening alone. Although the PDDP helped close overall screening gaps and detected cases of
undiagnosed dysglycemia, response rates to generic invitations were similar across racial/ethnic subgroups
(Hispanics 42%; NH Blacks 41%; NH whites 39%) and those with known PDM vs. unknown glycemic status
(38% vs. 41%). To address known screening and outcome disparities in racial/ethnic minorities and those with
PDM, equitable (not equal) screening is needed. In this proposal, we seek to improve the PDDP response in
racial/ethnic minorities and those with known PDM to achieve more equitable screening. To accomplish this,
we will develop Targeted (by race/ethnicity), Tailored (by known PDM vs. unknown glycemic state) (TT)
screening invitations (Aim 1) to increase engagement of high risk subgroups. We will then conduct a 3-arm
split-cluster RCT (Aim 2) to evaluate the efficacy of PDDP-delivered TT screening outreach + navigation of
non-responders vs. PDDP-delivered generic invitations to improve screening completion in high risk patients
and evaluate the effectiveness of the TT PDDP and Generic PDDP to improve screening completion vs. usual
care, opportunistic screening. Lastly, we will conduct cost-effectiveness analyses (Aim 3) to compare direct
costs and the cost per patient screened and case found across the three study arms. Together, these findings
will provide actionable evidence on clinical and cost-effective ways to close screening gaps in high-risk
patients. Because the PDDP is highly automated and scalable using a common EHR, our findings can be
practically implemented in most health systems. Our findings will have important implications for clinics and
health systems seeking to close T2D screening gaps and decrease screening disparities through scalable,
population-health T2D screening strategies to supplement opportunistic screening in usual care.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because 74 million US adults have undiagnosed prediabetes and 7.3 million have undiagnosed type 2 diabetes despite routine diabetes screening in clinical practice. Racial/ethnic minorities and those with known prediabetes are at increased risk for type 2 diabetes and experience screening disparities that contribute to delayed diagnoses and worse health outcomes. This proposal evaluates a screening strategy that supplements visit-based screening with a population health patient- outreach intervention to improve overall screening rates and decrease disparities in diabetes screening using specific messaging for racial/ethnic minorities and those with known prediabetes.